Vascular Discovery, From Genes to Medicine 2023

ABSTRACT
The Councils on Arteriosclerosis, Thrombosis, and Vascular Biology (ATVB) and Peripheral Vascular
Disease (PVD) of the American Heart Association (AHA) hold an annual Spring Meeting “Vascular Discovery:
From Genes to Medicine” the most recent of which (in-person) was held in Seattle, WA May 12-14, 2022.
This first post-pandemic in-person meeting was a resounding success with 507 attendees and 336 abstracts
submitted. Feedback from attendees was overwhelmingly positive, with the highest overall satisfaction
ratings in 4 years. These encouraging statistics provide tangible evidence of the broad interest and
commitment of the scientific community in the topic areas of ATVB, PVD and vascular medicine and the
overwhelming enthusiasm for the format and atmosphere of this meeting. Basic scientists, translational
researchers and clinicians, seasoned investigators and early career scientists, enjoy coming to this AHA
Spring meeting to share and learn cutting-edge vascular science and network with researchers across
disciplines. The next Vascular Discovery conference is scheduled to be held May 10-12, 2023 at the Marriott
Copley Place in Boston, MA. As with previous applications, this proposal specifically requests support for our
Young Investigator Travel Awards. Knowing that early stage investigators are the future of our scientific
progress, a major emphasis of our annual conference is to encourage the active involvement of the younger
cohort of investigators in the ATVB and PVD Councils of the AHA. This meeting provides early career
investigators with ample opportunities to present talks and posters and to participate in extensive career
development programming. Our Young Investigator Travel Awards have been supported by the NIH/NHLBI
for 16 years. These awards are an integral part of our strategy to recruit, retain and actively engage young
investigators in the fields of arteriosclerosis, thrombosis, vascular biology and vascular medicine research
that are of major importance to the NIH-NHLBI and the health of the U.S. population.

Public health relevance
This renewal application seeks support for Travel Awards for Young Investigators to attend the 2023 Vascular Discovery: From Genes to Medicine Scientific Sessions. This conference is organized by the Arteriosclerosis, Thrombosis, and Vascular Biology (ATVB) and Peripheral Vascular Disease (PVD) Councils of the American Heart Association. The Vascular Discovery conference provides unique opportunities for early stage investigators to meet peers, present their work, and interact with senior colleagues across distinct disciplines that have an interest in cardiovascular disease as a unifying theme.